Addressing structural racism to reduce racial disparities in youth firearm injuries

PROJECT SUMMARY
Dr. Jay’s long-term career goal is to become a leading independent investigator whose research contributes to
the elimination of racial/ethnic disparities in firearm violence, with a focus on city-dwelling youth. Most firearm
violence occurs in cities, where Black youth are 20 times more likely, and Hispanic youth are 4.4 times more
likely, to be fatally shot than non-Hispanic White youth at ages 18-24. The overarching goal of Dr. Jay’s
research project is to identify optimal strategies for reducing racial/ethnic disparities in youth firearm injuries in
cities. Specifically, this K01 tests whether disparities in youth firearm injuries can be reduced by bolstering
individual-level programs with two related interventions: (a) Desegregation policies, i.e., changing public policy
to decrease racial segregation across neighborhoods, and (b) Physical investments, i.e., improving the built
environment in disinvested areas. Dr. Jay will assess disinvestment as a pathway linking segregation with
youth firearm injury disparities (Aim 1); conduct participatory mapping with racial/ethnic minority youth in
Boston, MA to identify novel targets for physical investments (Aim 2); and test possible intervention strategies
in a computer-simulated environment to determine which strategies produce the greatest reductions in youth
firearm injury disparities, within realistic budgetary constraints (Aim 3).
The proposed research builds upon Dr. Jay’s prior research on place-based interventions for violence
prevention and his postdoctoral training in youth firearm injury and computational epidemiology. He will pursue
the following K01 training goals to prepare him for the proposed research and for his career goals: (1)
Structural racism and discrimination as drivers of health disparities; (2) Community-engaged research; (3)
Computer simulation modeling; and (4) Economic evaluation. Dr. Jay has assembled a mentorship team led by
his primary mentor, Dr. Emily Rothman, Professor of Community Health Sciences at Boston University School
of Public Health (BUSPH). Co-mentors include Dr. David Williams, the Chair of Social and Behavioral Sciences
at the Harvard T.H. Chan School of Public Health (HSPH); Dr. Melissa Tracy, Associate Professor of
Epidemiology and Biostatistics at SUNY-Albany; Dr. Ankur Pandya, Associate Professor of Health Decision
Science at HSPH. Advisors are Dr. Sandro Galea, the Dean and Robert A. Knox Professor at BUSPH and Dr.
Charles Branas, the Chair of Epidemiology at the Columbia Mailman School of Public Health. The resources
available at BUSPH, coupled with the expertise of Dr. Jay’s mentorship team, will ensure Dr. Jay’s successful
completion of the research and training aims and his development as an independent investigator.

Public health relevance
NARRATIVE In U.S. cities, Black youth are 20 times more likely, and Hispanic youth are 4.4 times more likely, to be fatally shot than non-Hispanic White youth at ages 18-24. To prepare for a career as an independent investigator focused on eliminating racial/ethnic disparities in youth firearm violence, Dr. Jay will train in structural racism and health disparities, community-engaged research, computer simulation modeling, and economic evaluation. His research will examine the potential benefits of desegregation policies and physical investments to reduce disparities in youth firearm injuries.